Cryopreservation of functional neutrophils by vitrification

ABSTRACT Neutrophils are among the first responders to infectious pathogens and play a critical role in host
survival. These phagocytic granulocytes migrate rapidly towards sites of infection, neutralizing bacterial and
fungal invaders. Neutrophil functional defects are observed in several primary immunodeficiencies (e.g. Chronic
Granulomatous Disease, Leukocyte Adhesion Disorder, Chédiak-Higashi Syndrome, etc) where inadequate
adhesion, migration, phagocytosis or oxidative killing is observed, often leading to severe or recurrent fungal and
bacterial infections. Though many assays have been developed to assess neutrophil function, these assays are
not part of routine clinical care and must be performed by specialized research laboratories. Since neutrophils
deteriorate rapidly, they should ideally be analyzed ~2-4 after collection, severely limiting their functional
analysis. This rapid deterioration prevents shipment of samples between laboratories or clinics, strains
experimental timelines and requires daily isolation of neutrophils from freshly collected peripheral blood
specimens. This short ex vivo shelf-life further complicates the use of neutrophils for the purpose of granulocyte
transfusion among neutropenic patients. A potential solution to this issue is the development of neutrophil
cryopreservation methods, as there is still no method to maintain functional neutrophils under cryogenic storage.
As such, the overall goal of this proposal is to develop a method to cryopreserve functionally active neutrophils.
Based on literature review and preliminary data, we hypothesize that vitrification will lead to improved recovery
of functional neutrophils. Vitrification is an `ice-free' method of cryopreservation where cells are loaded with high
concentrations of cryoprotective agents (CPAs, e.g. dimethyl sulfoxide) and rapidly cooled through the glass
transition. The result is formation of an amorphous glassy state as opposed to crystalline ice. We anticipate the
major challenge to vitrification will be neutrophil osmotic sensitivity, which complicates loading sufficiently high
concentrations of CPAs necessary to vitrify. We will overcome this challenge automating the procedure using
syringe pumps to minimize neutrophil volumetric changes during CPA loading. We will then optimize both
biochemical and phase transition aspects of neutrophil vitrification.
In Aim 1, we will characterize the biochemical properties of CPAs and optimize loading methods to prioritize
minimum toxicity vitrification CPA cocktails. As proof of concept, we will vitrify the CPA-loaded neutrophils using
previously reported microcapillaries. Thawed neutrophils will then be tested in a range of sophisticated functional
assays. In Aim 2, we will optimize the phase-transition parameters of vitrification by tuning the CPA
concentration, cooling/rewarming rates and thermal mass of the sample with a goal of vitrifying functional
neutrophils. As a result of this work, we anticipate that a robust vitrification protocol will be developed, enabling
the cryogenic storage of functional neutrophils.

Public health relevance
PROJECT NARRATIVE Neutrophils are phagocytic granulocytes that are among the bodies first responders to fungal and bacterial infections. Ex vivo, primary human neutrophils are extremely short lived, requiring daily isolation from fresh blood, a time-consuming process that strains experimental timelines and interferes with specimen transport. This project aims to improve public health by developing a method to cryopreserve functionally competent, primary human neutrophils to enable the on-demand availability of cells for researchers.